Senescent Cells Effects in Response to Pathogens

PROJECT SUMMARY/ABSTRACT
Aging is the broadest and most fundamental issue of our time because it affects all of society and underlies
multiple diseases throughout our lifespan. Dr. Larissa Langhi Prata is a biomedical researcher with an M.S. and
a Ph.D. in morphological sciences. She is an Assistant Professor of Physiology working in the equivalent of a
research track at the Robert and Arlene Kogod Center on Aging (KCA) at Mayo Clinic in Rochester, MN (MC),
who wants to pursue an independent tenure-track career in geroscience. Her research investigates the role of
senescent cells (SenCs) in the greater susceptibility of elderly and chronically ill patients to infectious diseases.
Her findings may allow us to develop novel, effective strategies for addressing this major health problem through
essential insights into the biology of aging and its links to the immune system. Her expertise regarding the
interplay between the immune system and non-immune SenCs makes her suited to engage in her research
goals. This career development plan will provide time and funds to enhance the skills required to carry out the
proposed activities and to become fully independent. The major training goals involve running immunological
assays, receiving hands-on digital pathology training to apply machine learning to image analysis, and
developing laboratory management/leadership skills. Dr. Langhi Prata has put together a stellar team of mentors
and advisors to coordinate her career development plans and research. Dr. Kirkland (primary mentor) and Dr.
Tchkonia (advisor) are leaders in the field of cellular senescence and senolytic therapy and have guided many
postdoctoral fellows to independent careers. Dr. Inna Ovsyannikova is an immunologist and a director of
laboratory studies at the Vaccine Research Group at MC. Her expertise in viral and bacterial vaccine-induced
immunity and being an active collaborator with Dr. Langhi Prata makes her the ideal co-mentor. Dr. Chady
Meroueh, a pathologist from the MC Department of Laboratory Medicine, is Dr. Langhi Prata’s co-mentor in the
digital pathology field and is knowledgeable in applying machine learning in healthcare image analyses. Dr. João
Passos’s research on aging and image analysis and Dr. Matthew Urban’s expertise in employing machine
learning for image analysis will act as advisors. Individually, these mentors and advisors are very accessible and
will function as a committee to assess Dr. Langhi Prata’s progress quarterly. MC, the DP, and the KCA provide
all the intellectual, technical, and infrastructural resources for Dr. Langhi Prata’s career development proposal
and are also committed to supporting junior faculty members through internal grants and fostering faculty
networking and collaboration. Dr. Langhi Prata will supplement her training and networking with workshops and
seminars outside MC. The long-term goal for this proposal is to equip Dr. Langhi Prata with unique skills in
immunology and digital pathology that will provide a singular interdisciplinary perspective to her independent
career in the geroscience field.

Public health relevance
PROJECT NARRATIVE Individuals with high senescent cell (SenC) accumulation (driven by age or chronic disease) are more susceptible to morbidity and mortality from infections caused by viral, bacterial, and fungal pathogens than healthier, younger individuals without a high pre-existing SenC burden. This proposal provides training for the principal investigator to isolate the role of SenCs as an underlying cause of postinfection morbidity through insights into the biology of aging and its links to the immune system, exploring sex discrepancies and therefore offering new supplementary treatment strategies for this vital health concern. The broad and significant translational potential of this application advances the NIA’s goal of improving the healthspan and well-being of older adults through biological research that specifically addresses the challenges and needs of this population.